Understanding Integration in Oncology Care and Association with Quality and Outcomes

PROJECT SUMMARY/ABSTRACT: Overall Program Project
This Program Project seeks to understand features of care integration in oncology that are associated with
higher-quality care delivery and better outcomes for individuals with cancer. Mergers and acquisitions (a form
of structural integration) among care delivery organizations have increased substantially in the past decade,
particularly in oncology. Yet, such ownership changes are only one form of structural integration; structural
features such as co-location, referral networks, and geographic reach also influence care delivery. Moreover,
other forms of integration, including functional, normative, interpersonal, and process integration, are also
important for organizations to provide integrated care. Structural integration via ownership changes is unlikely
to lead directly to better care delivery on its own. Learning how organizations engage in various forms of
integration is critical to understanding how different types of integration influence care. In this Program Project,
we propose a novel research effort with four interrelated Projects reflecting different types of organizations that
deliver cancer care. The organizations include health systems, independent oncology practices, post-acute
care and hospice entities, and specialty pharmacies. Project teams will collect primary data from case studies
and surveys and use administrative data from public and commercial insurers to explore the following aims:
Aim 1. Using case studies, adapt an existing conceptual framework and describe key forms of care integration
beyond structure (i.e., functional, normative, interpersonal, process) for oncology care that are most relevant
for integrated patient care experiences across settings and across the cancer continuum. Identify mechanisms
through which forms of integration may produce integrated patient care and better and more equitable (i.e.,
narrowing gaps in receipt of high-quality care for marginalized groups) outcomes.
Aim 2. Measure and compare oncology care integration across settings and assess how these key forms of
integration are associated with one another. Assess how structural features, practice factors (e.g., proportion
marginalized patients), and market factors relate to non-structural forms of integration (functional, normative,
interpersonal and process).
Aim 3. Assess the association of key forms of integration with utilization, spending, and high-quality and
equitable care within and across care settings, including health care systems, independent oncology practices,
post-acute care and hospice, and specialty pharmacies, and assess mechanisms through which care
integration improves or worsens overall outcomes and receipt of equitable care for marginalized subgroups
based on race and ethnicity, residence in rural areas, and socioeconomically deprived areas.
Defining and assessing how health care organizations integrate oncology care for patients with cancer and
understanding how integration is associated with key outcomes of cancer treatment will inform policies and
practices that can drive improvement in patient outcomes and patient, clinician, and staff experiences.

Public health relevance
PROJECT NARRATIVE: Overall Program Project This Program Project involves a novel research effort with four interrelated Projects pertaining to types of organizations that deliver oncology care to understand features of care integration that are associated with higher-quality care delivery, more equitable care, and better outcomes for individuals with cancer. Defining and assessing how health systems, independent practices, post-acute care and hospice organizations, and specialty pharmacies integrate oncology care for patients with cancer and understanding how integration is associated with key outcomes of cancer treatment will inform policies and practices that can drive improvement in patient outcomes and patient, clinician, and staff experiences.